Regulation of mitochondrial activity and metastasis by dihydrouridine-modified tRNAs in renal cell carcinoma

PROJECT SUMMARY
This project will investigate the impact of dihydrouridine (D) modifications in tRNA on a newly discovered post-
transcriptional regulatory mechanism called P-site tRNA-mediated decay (PTMD), and the resulting effects on
mitochondrial metabolism and cancer metastasis. PTMD is a pathway wherein specific arginyl-tRNAs recruit the
CCR4-NOT complex to ribosomes translating mRNAs rich in CGG, CGA, and AGG arginine codons, resulting
in reduced translation and accelerated turnover of these transcripts. Since mRNAs that encode components of
mitochondrial ribosomes and the respiratory chain are rich in these codons, reduced efficiency of PTMD results
in an increase in mitochondrial activity. Recently, activation of mitochondrial respiration was shown to drive
metastasis in clear cell renal cell carcinoma (ccRCC), but how metastatic ccRCC cells upregulate mitochondrial
activity remains unclear. Overexpression of multiple dihydrouridine synthase (DUS) enzymes that introduce D
modifications at specific positions in tRNAs is also strongly associated with poor patient survival in ccRCC.
Moreover, DUS overexpression is associated with upregulation of transcripts rich in CGG/CGA/AGG arginine
codons, including those encoding mitochondrial proteins, indicative of PTMD impairment. Based on these
findings, we hypothesize that DUS overexpression results in D hypermodification of tRNAs, reducing their ability
to recruit the CCR4-NOT complex, and thereby increasing the translation and stability of CGG/CGA/AGG-rich
mRNAs encoding components of mitochondrial ribosomes and the respiratory chain. In ccRCC, the increase in
mitochondrial metabolism and respiration that results from this translational reprogramming is predicted to
promote metastasis, resulting in poor patient outcomes. To investigate this hypothesis, our research program
will examine how altering DUS enzyme activity affects tRNA D modifications, overall tRNA metabolism, and the
PTMD pathway in human and mouse ccRCC cells, documenting the effects of both individual and combinatorial
D modifications at multiple tRNA positions. Using ccRCC models, we will evaluate the impact of gain and loss of
DUS enzyme activity, as well as mutations in the CCR4-NOT subunit CNOT3 that impair PTMD, on mitochondrial
activity and metastasis in this malignancy. Cryo-electron microscopy (cryo-EM) will be used to investigate the
molecular mechanisms whereby D hypermodification of tRNAs influences tRNA structure and CCR4-NOT
recruitment. Altogether, these experiments will provide a mechanistic understanding of the impact of
dihydrouridine modifications on PTMD and ccRCC pathogenesis, potentially revealing new therapeutic
vulnerabilities in this malignancy. We have assembled a complementary team of experts in RNA biology, post-
transcriptional regulation, metabolism, cancer biology, and structural biology to accomplish these aims, and we
are eager to collaborate with other groups in the RNAMoDO program to investigate how additional RNA
modifications impact normal physiology and cancer.

Public health relevance
PROJECT NARRATIVE Metastatic clear cell renal cell carcinoma (ccRCC) is a deadly malignancy with limited effective treatment options. This project will investigate a new mechanism that promotes metastasis in ccRCC by regulating the degradation of messenger RNAs and, consequently, the activity of mitochondria, cellular organelles that fuel metastatic progression in this malignancy. The results of this research have the potential to significantly impact public health by identifying new strategies to treat aggressive kidney cancer.